Associations between neurophysiological discrimination and clinically observable sensory reactivity features in infants

PROJECT SUMMARY/ABSTRACT
Hyper- and hypo-reactivity in response to sensory stimuli, particularly to auditory stimuli, are prevalent
across the lifespan in populations with neurodevelopmental conditions including autism. Although hyper- and
hypo-reactivity are widely documented in infants at increased likelihood for neurodevelopmental conditions
(LNC), the neurophysiological underpinnings of these clinically observable sensory reactivity features have not
yet been established in infancy, a developmental period in which the brain is most plastic. Studies have shown
differences in neurophysiological discrimination may distinguish autistic and non-autistic school-age children.
This suggests that neurophysiological discrimination is a potential underlying mechanism of clinically
observable sensory reactivity features. Research with autistic school-age children has shown links between
reduced neurophysiological discrimination and hyper-reactivity features, while the research regarding
associations with hypo-reactivity features is sparse and conflicting. However, the associations between brain
and behaviors have not yet been tested in infants with different levels of risk for later neurodevelopmental
conditions. In this proposal I seek to extend research to an earlier developmental period by examining infants
with low vs. high LNC levels through two specific aims. Aim 1: Compare within-session trajectories of
neurophysiological discrimination responses to auditory stimuli between low and high LNC infants; and Aim 2:
Examine how these neurophysiological discrimination trajectories associate with clinically observable sensory
reactivity features. Over two years, I will measure neurophysiological responses of discrimination to an auditory
in 60 infants aged 9-12 months using event-related potential (ERP). I will also collect behavioral assessments
(observed and parent-report) on clinically observable sensory reactivity features. The long-term objective of
this study is to elucidate the origins of sensory processing difficulties and their impact on developmental
outcomes. The significance of this research lies in its potential to promote a more comprehensive conceptual
model linking neurophysiological mechanisms to sensory behavior that can guide more precise clinical
assessment and improved intervention approaches in the future. The PI on this training fellowship is a
postdoctoral research associate in the University of Southern California’s Chan Division of Occupational
Science and Occupational Therapy. The PI will work with a mentorship team of experts in the fields of
neurophysiology and clinically observable sensory reactivity to complete a comprehensive investigation of
neurophysiological underpinnings of clinically observable sensory reactivity features in infants at varying LNC,
contributing to the brain-behavior understanding early in life. This study will help the PI to launch her career as
an independent scientist with a research focus on biomarkers of clinical sensory behaviors in infants and
young children with varying levels of LNC.

Public health relevance
PROJECT NARRATIVE This research is relevant to public health because it will uncover biomarkers of clinically observable sensory features that significantly impact children with neurodevelopmental conditions such as autism. This research will shed light on the origins of sensory processing difficulties and provide valuable insights into early brain development for at-risk populations. Further, these empirical findings will strengthen conceptual models of brain-behavior linkages related to sensory processing deficits, which in turn will inform more effective targeted interventions for infants at increased likelihood for neurodevelopmental conditions, ultimately improving developmental outcomes.